Defining the Role of Intestinal Calcium Channels in Alcoholic Liver Damage.

Alcohol-related diseases and disorders (ADD) account for over 5% of global health problems, and alcohol
abuse is a causal factor in more than 200 diseases. Endotoxemia and systemic inflammation are common
conditions associated with morbidity and mortality in various ADD. Extensive clinical and experimental
evidence indicates that disruption of intestinal epithelial tight junction and mucosal barrier dysfunction are
prerequisite steps in alcoholic endotoxemia, systemic inflammation, and ADD. A critical barrier in the field is
that the mechanisms of alcohol-induced tight junction disruption are poorly defined. Hence, the current
treatment for ADD remains empiric (e.g., corticosteroids). Our long-term goal is to describe the
pathophysiology of ADD and develop novel therapeutic strategies by targeting gut barrier dysfunction. TRPV6
and CaV1.3 are Ca2+ permeable ion channels on the apical membrane of the intestinal epithelium. Our
preliminary studies have identified that: 1) Calcium influx from the apical membrane is required for the
synergistic disruption of intestinal epithelial tight junction and barrier dysfunction by alcohol. 2) TRPV6 or
CaV1.3 deficiency attenuates alcohol-induced epithelial permeability. 3) TRPV6 is required for alcohol-induced
elevation of intracellular calcium, 4) Alcohol evokes ionic currents in Caco-2 cells sensitive to SOR-C13, a
TRPV6 inhibitor. 5) TRPV6 or CaV1.3 deficient mice are resistant to alcohol-induced gut permeability. 6) SOR-
C13 prevents the alcohol-mediated epithelial permeability. These findings form the scientific premise and
support the central hypothesis that TRPV6 and CaV1.3 channels drive alcohol-induced endotoxemia and
systemic inflammation by enforcing intestinal epithelial TJ disruption and mucosal barrier dysfunction. We will
test this hypothesis by determining that 1) the coordinated activities of TRPV6 and CaV1.3 channels mediate
alcohol-induced rise in cellular calcium in the intestine, 2) TRPV6 and CaV1.3 channels mediate alcohol-
induced gut permeability, endotoxemia, and systemic inflammation, and 3) evaluate the preventive and
mitigating potential of SOR-C13 and diltiazem, the calcium channel blockers, in alcohol-induced endotoxemia
and systemic response. The expected outcome of these studies will be a deeper understanding of the
intestine’s role in the pathophysiology of ADD and the identification of rationally designed novel therapeutic
targets for the prevention and treatment of ADD.

Public health relevance
One in eight adult Americans are alcoholics1, and more than 18 million Americans are estimated to have alcohol- related diseases and disorders (ADD), including hepatitis, pancreatitis, and neurodegenerative disorders. We propose to conduct studies to uncover the cellular and molecular mechanisms involved in alcohol-mediated multiple organ damage and identify calcium channels in the intestine as therapeutic targets for developing therapeutics for treating ADD. These studies are expected to determine the calcium channel blockers as potential therapeutic agents for the treatment of patients with ADD.